Pediatric Outcomes of Prenatal Zika Exposure II

SUMMARY
Zika virus (ZIKV) is an emerging Flavivirus transmitted by Aedes species mosquitoes, sexual contact, blood
transfusions or vertically from mother to fetus. While most ZIKV infections are asymptomatic, infection during
pregnancy can result in fetal loss or congenital ZIKV infection with microcephaly or other central nervous system
(CNS) damage. The study team hypothesizes that neurobiological, environmental and system factors contribute
to deleterious cognitive and reduced social and emotional school readiness in children born to mothers with
laboratory confirmed ZIKV PCR positive and possible ZIKV IgM positive infection during pregnancy. The study
team expects to improve the knowledge of the full spectrum of outcomes of congenital ZIKV infection during the
critical developmental period of early childhood that should translate into better practices in the provision of
services and support to families, many of which are disadvantaged. This evidence will be useful for clinicians to
identify subtle neuro-developmental and behavioral abnormalities as they manifest and for families to seek early
services to improve health and quality of life. The proposed research addresses the specific objective of the
National Institute of Minority Health and Health Disparities to improve minority health and reduce health
disparities. Aim 1 will track sensory, neurologic, developmental and behavioral outcomes and assess whether
the abnormalities identified are permanent or transient or become evident over time from birth to school age.
Aim 2 will expand knowledge on how environmental factors influence the outcomes of congenital ZIKV infection
and which factors can be considered protective or damaging to implement preventive measures. Aim 3 will
assess health equity by evaluating the access and quality of healthcare. The results obtained will help guide best
practices aimed at reducing health disparities. The exploration of family dynamics that affect child development
will help caregivers and providers assess and implement best practices. The identification of environmental
factors will allow timely actions by agencies and the community that could protect against further damage to the
developing brain. The team is confident that lessons from health equity can empower families to overcome the
limitations posed by their child's congenital anomalies and developmental disabilities and increase awareness
of health care providers to remove barriers to access and improve adherence. Adequate health care models will
show when and how it is best to intervene while informing policy regarding system's improvements for healthier
children.

Public health relevance
PROJECT NARRATIVE Zika virus infection during pregnancy can result in a spectrum of outcomes that jeopardize the health and well- being of infected infants and children potentially hampering their ability to achieve success when they reach school. Capitalizing on a partnership between the Centers for Disease Control and Prevention, San Lucas Episcopal Hospital, Damas Hospital and Ponce Health Sciences University, this study will enroll and follow infants and children born to mothers infected with the Zika virus during pregnancy. The proposed study includes a comprehensive longitudinal assessment of neurobehavioral development, environmental factors and healthcare service access through school readiness, particularly in infants with no detectable adverse outcomes at birth.